Regulation of vitamin A metabolism in the eye

ABSTRACT:
In a healthy eye, the proper homeostasis of vitamin A (all-trans-retinol, atROL) supports visual function under a
variety of lighting conditions. However, certain environmental insults in combination with an unfavorable
genetic background can overcome the adaptive capabilities of ocular retinoid metabolism and compromise
retinal function. The clinical examples are Stargardt disease, an inherited form of juvenile macular
degeneration and Age-related macular degeneration (AMD), in which an imbalance in retinoid metabolism is
an important etiologic factor. Despite intensive studies, FDA approved treatments for inherited or acquired
degenerative retinal diseases are very limited. In this project, we propose to expand potential treatment options
for the retinal degenerative diseases by developing a safe and effective method of controlling the ocular flux of
retinoids by targeting vitamin A binding proteins. To obtain insight into the potential therapeutic applications of
this approach, we propose comprehensive studies that combine diverse biochemical, biophysical, and
physiological methods aimed at developing candidate drugs and assessing their biological effects in animal
models of human retinal degenerative diseases.
To achieve these goals, we propose three specific aims. In Aim 1, we will utilize high-throughput screening
(HTS) technology to identify small-molecule antagonists of cellular retinol-binding protein (CRBP1). We will
select lead compounds and characterize their binding properties. We will also validate their biological activity in
a cell-based secondary assay. Ultimately, we will pre-select the first-in-class drug candidates that allow for the
pharmaceutical manipulation of retinoid metabolism. In Aim 2, the therapeutic potential of CRBP1 ligands will
be assessed by evaluating changes in biochemical and pathophysiological processes in the retinas in vivo.
The results of experimental therapies will be monitored by electroretinograms, non-invasive imaging
techniques, including optical coherence tomography, scanning laser ophthalmoscopy, and two-photon
microscopy, whereas ocular retinoid metabolism will be examined with advanced analytical tools. Ultimately,
we will link the biochemical properties of CRBP1 antagonists with their therapeutic effects, and thus provide
solid proof-of-concept data that could be further developed into initial clinical trials. In Aim 3, we will combine
the structural information about the mode of non-retinoid ligands interaction with CRBP1 and methods of
medicinal chemistry to rationally improve pharmacodynamic properties of drug candidates. We will also
determine pharmacokinetics of the selected drug candidates in the context of their ability to cross the
blood/retina barrier. The completion of these experiments will identify the chemical properties that provide the
best efficacy profile for the lead compounds.
Together, our studies will contribute a novel mechanism-based therapeutic strategy for blinding eye conditions
and first-in-class drug candidates pre-tested in vivo that will expand treatment options for millions of patients
affected by retinal degenerative diseases.

Public health relevance
NARRATIVE: Effective therapies for blinding retinal degenerative diseases are unmet medical needs. Retinaldehyde reactivity and the accumulation of its metabolites is an etiologic factor in retinal and macular degenerations of multiple causes. Thus, research towards the development of pharmacological approaches to influence retinoid metabolism promises new methods for the prevention of these ocular conditions. In this proposal, we validate cellular retinol-binding protein 1 as a relevant therapeutic target and identify a new class of drugs effective against progressive retinal degeneration.